Multi-scale functional connectivity in preclinical models of Parkinson's disease

PROJECT SUMMARY / ABSTRACT:
Parkinson’s disease is a progressive neurodegenerative disorder and is associated with significant motor and
non-motor symptoms, traceable to the loss of nigral dopamine neurons in addition to widespread circuit
dysfunction extending beyond the dying nigrostriatal tract. Imaging-based biomarkers play a critical role in
assessing Parkinson’s-related pathological changes, but current biomarkers are limited in their diagnostic and
prognostic ability, particularly in early disease stages when intervention would be most beneficial. Functional
magnetic resonance imaging (fMRI) enables the study of brain activation and has been widely used to study
global functional network changes in Parkinson’s disease. However, standard fMRI is limited in its ability to
robustly measure subtle changes with disease, in part due to low sensitivity and specificity; furthermore,
interpretation of standard fMRI is challenging due to the indirect link between neuronal function and MRI signal
change. This lack of robust direct biomarkers is a critical gap that ultimately limits our ability to understand the
underlying pathological changes, as well as evaluate emerging therapies. To overcome these limitations, we
propose to leverage an advanced multi-contrast fMRI method that provides high contrast sensitivity, as well as
distinct microvascular sensitivity. By coupling this method with pharmacological and chemogenetic
manipulations, a direct link between fMRI-based functional networks and underlying neuronal function can be
inferred. More specifically, this project aims to a) characterize multi-contrast (total vascular and microvascular)
functional connectivity networks in two complementary preclinical models that recapitulate classic hallmarks of
Parkinson’s disease - the progressive PFF synucleinopathy model and the acute 6-OHDA model; b) assess the
effect of pharmacological dopamine modulation on functional networks, using both acute and chronic treatment
paradigms, analogous to the standard treatment paradigm; and c) investigate the effect of endogenous
modulation of the dorsal raphe serotonergic circuit and the locus coeruleus noradrenergic circuit – both of which
are proposed to be involved in certain non-motor symptomology – on functional networks using chemogenetic
methods. These studies will provide insight into functional network changes that occur over different vascular
scales and via different neurotransmitter populations. The development of robust MRI biomarkers that relate to
dopaminergic, serotonergic, and noradrenergic circuit function and dysfunction may also provide insight into the
multifaceted nature of Parkinson’s disease that contributes to both motor and non-motor symptoms. As functional
brain network dysfunction is widely observed in Parkinson’s disease, this integrative approach will enable the
development of robust biomarkers of Parkinson’s disease with well-characterized pathophysiological origins,
which is a critical shortcoming of current technologies.

Public health relevance
PROJECT NARRATIVE: This goal of this proposal is to investigate Parkinson’s-related changes in brain networks using a robust functional magnetic resonance imaging method, which increases sensitivity to brain activity and informs on microvascular function. This method will be used to characterize changes with Parkinson’s disease in preclinical models, as well as investigate changes in brain networks with specific biochemical modulations. These studies will provide insight into the underlying causes of altered brain networks observed in Parkinson’s disease.